Methodology Core

ABSTRACT - METHODOLOGY CORE
Clinical research in total joint arthroplasty (TJA) demands the highest standards of study design while
leveraging existing data sources and adopting standardized definitions and novel clinical research
methodologies. TJA researchers need to be well-trained and supported if they are to respond effectively to
current and emerging research gaps in TJA. The Mayo Core Center for Clinical Research in Total Joint
Arthroplasty (CORE-TJA) Methodology Core will build upon Mayo’s existing methodology resources to
advance the science of TJA clinical research at the national level by providing high-quality consulting,
education and mentoring services, and state-of-the-art and novel methodology resources, facilitating optimal
use of existing stand-alone or linked databases and clinical research networks, training of the next generation
of TJA clinical investigators and building scientific collaborations. The Specific Aims of the CORE-TJA
Methodology Core are: (1) To enhance TJA clinical research at the national level by providing consultation,
education and mentoring services for TJA investigators, (2) To leverage existing databases and clinical
research networks to identify the most informative study populations and study designs for TJA clinical
research, and (3) To develop and disseminate novel methodologies applicable to observational and
interventional study designs in TJA clinical research. Specifically, the Methodology Core will focus on 6
specific methodological areas in TJA research: methods to account for bias and confounding in TJA research,
application of TJA-specific informatics tools for automated data extraction from the electronic health records,
patient-reported outcomes research, clinical trials embedded in registries and/or healthcare systems, mixed-
methods research and implementation research. The CORE-TJA Methodology Core will create a flexible,
sustainable research infrastructure, trained workforce and synergistic collaborations at the national level.

Public health relevance
NARRATIVE The Mayo Core Center for Clinical Research in Total Joint Arthroplasty (CORE-TJA) will provide methodological expertise and access to nationwide data resources to facilitate innovative, methodologically rigorous and interdisciplinary clinical research in TJA. The clinical research needs of the TJA research community that will be addressed by the CORE-TJA include training of the next generation of TJA researchers, customized consultations, facilitated access to high quality, rich data sources and national TJA registry data as well as informatics and methodology support.